Task A78: Mouse and Guinea Pig Models for Cytomegalovirus and Herpes Simplex Vviruses

This contract provides for the development of new and refinement of existing models of infectious diseases and may include evaluation of candidate countermeasures.